CANCER RESEARCH TRAINING PROGRAM

The University of Pennsylvania Cancer Research Training Program prepares the next generation of cancer researchers by providing protected time in an environment dedicated to the enhancement of research skills and concepts. The Cancer Center has demonstrated its ability to consistently meet the aims of the training program throughout the past fifteen years. Six post-doctoral trainees, who have completed their training in the clinical aspects of medical oncology, radiation oncology or pathology receive two years of research training in contemporary biomedical or clinical investigation under the tutelage of senior scientists. These experienced research mentors are drawn from the Cancer Center's Basic Research Programs (Immunology, Virology, Cell and Developmental Biology, Cancer Genetics); Clinical Investigations Program (e.g., Clinical Investigation, Melanoma, Breast Cancer, Radiation Biology, and Pediatric Oncology), which conduct clinical trials with laboratory correlates; and Cancer Control Programs. The training program is specifically designed to select, prepare, and motivate trainees to pursue academic positions in oncology. The integrated curriculum involves formal course work, research seminars and conferences, lecture series, and supervised research projects. Those pursuing clinical research are expected to complete a master's level curriculum in one of the following areas: clinical cancer epidemiology and biostatistics, genetic epidemiology, health services and outcomes research, or cancer pharmacology and experimental therapeutics. An Executive Committee oversees trainee selection and recruitment, the training program, and evaluates individual trainee progress. The Cancer Center is a long-standing NCI-designated Comprehensive Cancer Center, and is recognized for its interdisciplinary research programs, integration of basic and clinical investigation, and patient care. Fourteen Shared Resources facilitate cancer investigation. Extensive trainee research opportunities spanning all aspects of cancer research are available through the University of Pennsylvania and its School of Medicine, The Children's Hospital of Philadelphia, Wistar Institute, and Veterans' Administration Medical Center, all of which have an outstanding record in cancer research and are located on a single campus.